Administrative Core

Project Summary – Administrative Core
The main goal of the Administrative Core is to maximize the Center Core's effectiveness in responding to the
research needs of participating investigators and to impact the advancement of basic and translational vision
research. The Administrative Core will provide support for the management of the Center Core by coordinating
and integrating activities of the individual Resource Cores. It will provide an organizational infrastructure for
optimal efficiency and integration of Core activities to ensure and promote accessibility and utilization of shared
resources by participating investigators. The Administrative Core will implement procedures and support
mechanisms to: 1) evaluate and monitor the utilization, effectiveness and quality of services provided by
Resource Cores; 2) integrate activities and synergize interactions of Resource Cores; 3) allocate appropriate
centralized resources for optimal functioning of Resource Cores; 4) organize programs for fostering and
facilitating the use of new emerging technologies and inter-disciplinary vision science research.